Retrovirus Models of Cancer

OVERALL PROJECT SUMMARY
This competitive renewal application (P01CA100730) seeks funds to continue our highly integrated studies of
retrovirus models to elucidate cellular mechanisms of lymphocyte transformation and associated
lymphoproliferative disease. Infection of CD4+ T-cells with the human retrovirus, human T-cell leukemia virus
type 1 (HTLV-1), induces their immortalization and enables those cells to accumulate genetic mutations leading
to the malignant cancer, adult T-cell leukemia (ATL). The advantage of the HTLV-1 model to study
leukemogenesis is the rapid induction of T-cell immortalization brought about by the viral infection. This model
of leukemogenesis allows careful examination of the biologic changes and response patterns of virus infected
preneoplastic cells while under the influence of cellular and viral factors that control and perhaps promote
progression to cancer. In the previous funding period, we made substantial advances in our understanding of:
1) how retrovirus accessory proteins contribute to cell immortalization; 2) how retroviruses cause broad cellular
changes that position infected cells to progress to a metastatic cancer; 3) and how ATL cells contribute to
paraneoplastic disease syndromes, and can be targeted for anticancer therapy. In the next funding period, the
overall theme of the Program Project is to continue our studies with HTLV-1 leukemia model with a focus on
discovering how key viral, cellular and microenvironmental factors work in concert to promote T-cell cancer. We
now recognize three interrelated areas of study that are major gaps in our understanding of the pathogenesis of
HTLV-1-associated T-cell leukemogenesis: 1) Mechanism of action of HTLV-1 multifunctional hbz mRNA and
HBZ protein; 2) The effect of HTLV-1 CTCF-BS (11-zinc finger CCCTC factor-binding site) on T-cell
immortalization, hbz expression, establishment of latency and contribution to the transition to ATL, and; 3)
Microenvironmental factors that contribute to the survival and expansion of HTLV-1-infected T-cells and their
progression to ATL.

Public health relevance
OVERALL PROJECT NARRATIVE The ultimate goal of this P01 Program Project Grant (PPG) competitive renewal application is to utilize the HTLV-1 T-cell immortalization model to gain understanding of the microenvironmental, cellular and viral factors that lead to progression to leukemia, and with this knowledge, to identify unique targets for diagnosis and treatment of HTLV-1 infection and ATL and related leukemia/lymphoma.